Critical roles of endogenous TLR signaling in driving Th17 effector responses

DESCRIPTION (provided by applicant): This proposal will investigate the direct regulation CD4+ T lymphocyte function through the TLR2 and TLR4 signaling pathways. We have previously shown that TLR2 activation in T cells can drive the generation and effector function of Th17 cells. Our preliminary data indicates that TLR4 signaling additionally may function in a similar manner within T lymphocytes through the promotion of proliferation and survival. Furthermore, direct activation of the TLR2 or the TLR4 pathway in CD4+ T cells promotes the development of experimental autoimmune encephalomyelitis (EAE), the mouse model of multiple sclerosis. Importantly, CD4+ T cells were found to promote the pathogenesis of EAE through the activation of TLR2 by endogenously generated signals that are released as a byproduct of inflammation. Whether the same is true for endogenous TLR4 signaling has yet to be determined. Thus, we will first perform EAE using a model of WT and TLR4-deficient CD4+ T cell transfer in the absence of exogenous TLR4 stimuli to determine the potential importance of this pathway in driving autoimmune inflammation. Furthermore, we aim to ascertain the identity of such endogenous TLR signals capable of activating the TLR2 and TLR4 pathways in Th17 cells. Two candidate molecules have been identified, HMGB1 and biglycan, both of which stimulate TLR2 and TLR4 and are found in inflamed CNS tissue. We will also investigate is targeting these endogenous TLR ligands, rather than TLRs themselves, is a viable strategy for EAE/MS therapy. These studies will include directly neutralizing endogenous ligands through antibody treatment. Our in vitro observations have clearly demonstrated that TLR2 signaling promotes proliferation and the direct polarization of naive CD4+ T cells into the Th17 lineage. TLR4 signaling, on the other hand, had no such effect on lineage commitment but instead enhanced proliferation and survival of Th17 cells. These results collectively suggest that under sub optimal conditions, signaling through either TLR could enhance Th17 cytokine production and the persistence of this inflammatory subset. Thus, we will analyze the epigenetic, signaling, and transcriptional mechanisms TLRs utilize to regulate proliferation, survival, and the production of IL-17 in CD4+ T lymphocytes. Our laboratory has found that specific histone modifications enriched at the IL-17 locus allow permissive access of the transcriptional machinery during Th17 differentiation. Furthermore, TLR2 activation on Th17 cells enhanced the expression of Th17-related transcription factors such as RORγt. Thus, we will determine if histone H3 acetylation and methylation events are amplified through TLR2 signaling during Th17 differentiation. Additionally, we aim to globally investigate the downstream targets of TLR2 and TLR4 signaling in CD4+ T cells through microarray analysis. Identification of novel signaling and transcriptional pathways governing T cell survival and cytokine production as a result of TLR signaling will provide new lines of experimentation that will allow the candidate to establish an independent laboratory, gain separation from the research interests of the current mentor, and aid in the application for R01 funding.

Public health relevance
Project Narrative This proposal addresses the direct role of toll-like receptor signaling in T cells during the development of inflammation. Our previous research has shown that toll-like receptor activation in T lymphocytes can promote the development of a mouse model of multiple sclerosis. This proposal will directly examine the mechanisms for these findings with the overall goal being the development of new therapeutic strategies in the treatment of autoimmune disease such as multiple sclerosis. PROJECT NARRATIVE: This proposal addresses the direct role of toll-like receptor signaling in T cells during the development of inflammation. Our previous research has shown that toll-like receptor activation in T lymphocytes can promote the development of a mouse model of multiple sclerosis. This proposal will directly examine the mechanisms for these findings with the overall goal being the development of new therapeutic strategies in the treatment of autoimmune disease such as multiple sclerosis. __SpecificAimsTextDelimiter__ Specific Aims Naïve CD4+ T helper cells (Th) differentiate into distinct effector lineages upon recognition of cognate antigen. Recently, an IL-17-producing Th subset, termed Th17, was characterized and found to be substantially involved in the promotion of autoimmune inflammation, such as that observed in the CNS of multiple sclerosis (MS) patients. Our group and others have described an essential role for IL-17 in the promotion of MS as well as in the corresponding murine model, experimental autoimmune encephalomyelitis (EAE); however, the regulatory mechanisms governing IL-17 production in MS/EAE have yet to be fully characterized. Our preliminary results demonstrated that TLR2 and TLR4 signaling in T cells can promote IL-17 production and the development of EAE, but the precise mechanisms utilized by TLRs to control Th17 function requires further investigation. Herein, this proposal will address the regulation of Th17 cell function through the TLR2 and TLR4 pathways with a specific emphasis on the promotion of central nervous system inflammation by endogenously generated TLR ligands. The central hypothesis being tested is that TLR2 and TLR4 are critical pathways necessary for CD4+ T cells in the full promotion of IL-17 responses during EAE/MS development and pathogenesis. Specific Aim I: To determine the physiological relevance of endogenous TLR signaling in Th17 cells Rationale: TLR2 or TLR4 expression by CD4+ T cells is detrimental for the development and ensuing severity of EAE disease. Furthermore, we have demonstrated that endogenous TLR2 ligands are generated in the CNS following EAE induction. The endogenous TLR2 signaling pathway was critical in promoting the effector function of Th17 cells during EAE; however, we are unsure if the same is true for endogenous TLR4 signaling. Finally, although our laboratory has established a link between endogenous TLR activation in CD4+ T cells for the promotion of EAE, we have yet to characterize the identity of such endogenous ligands and their relevance in modulating Th17 responses during autoimmune inflammation. Working Hypothesis: CNS inflammation induces the release of endogenous HMGB1 and biglycan, which amplify Th17 responses through direct activation of TLR2 and TLR4. Methodology: We will investigate the identity and function of endogenously generated TLR ligands in the promotion of Th17 responses as well as addressing the feasibility of targeting the endogenous TLR2 and TLR4 pathways as a novel EAE/MS therapy. Specific Aim I will address the following aspects of Th17 TLR2 and TLR4 signaling in vivo: a). To determine if endogenous TLR4 ligands drive effector Th17 responses in the CNS during EAE b). Characterization and therapeutic evaluation of endogenous HMGB1 and biglycan in the promotion of Th17 responses during EAE Specific Aim II: Examination of the regulatory targets downstream TLR activation in CD4+ T cells Rationale: Our preliminary data indicates that both the TLR2 and TLR4 pathways are important in the regulation of CD4+ T cell function: TLR signaling positively regulates proliferation, survival, and IL-17 production. Still the epigenetic, transcriptional, and signaling mechanisms controlling these TLR-dependent activities remain undefined. TLR signaling in innate cells can regulate gene expression at both the transcriptional and epigenetic level. However, the epigenetic, transcriptional, and signaling mechanisms downstream TLR activation in CD4+ T cells are poorly understood. Interestingly, EAE disease was similar when examining TLR2-/- or TLR4-/- CD4+ T cells, indicating a lack of redundancy between these pathways in the promotion of Th17 activity. Thus, uncovering the unique regulatory mechanisms that TLR2 or TLR4 utilize to promote Th17 generation and effector function remains a priority for a better understanding of Th17 biology and disease pathogenesis. Working Hypothesis: TLR2 signaling promotes Th17 differentiation and IL-17 production through permissive histone H3 modifications at Th17-related gene loci. TLR4 signaling promotes the persistence of the Th17 subset by regulating survival pathways in a manner similar to innate cells. Methodology: We will utilize epigenetic studies and high throughput analysis to address the following aspects of IL-17 regulation, proliferation, and survival by TLR2 and TLR4 signaling in CD4+ T cells: a). To determine if TLR2 activation promotes Th17 function through permissive histone H3 acetylation and methylation events at the IL-17 locus b). To identify the mechanisms downstream TLR2 and TLR4 signaling that govern cytokine production, proliferation, and survival in CD4+ T cells